Disruption of the circadian clock in lung cancer

Project Summary
Disruption of the molecular circadian clock is indicative of poor prognosis in non-small cell lung cancers
(NSCLCs), but direct evidence for a causal link between circadian clock deregulation and malignancy in human
cancer is missing. We found that BMAL1 is downregulated in human NSCLCs, indicative of circadian
disruption, low BMAL1 is an indicator of aggressive disease and poor prognosis. In addition, deletion of
BMAL1 in a mouse model of NSCLC accelerates cancer progression. These data suggest that BMAL1, and by
extension, circadian rhythms, exert a tumor-suppressive role in lung cancer. However, how BMAL1 restrains
tumorigenesis and the mechanisms involved in suppression of BMAL1 remain unclear. A potential cause for
BMAL1 suppression is the upregulation of MYC-family oncoproteins, which are amplified 50% of NSCLCs. We
were the first to show that the molecular clock is disrupted by amplified MYC. In addition, our preliminary data
suggest that, even in the presence of glucocorticoids, MYC suppresses BMAL1 expression in both NSCLC and
normal lung epithelium, and thus disrupts circadian clock oscillation. To date, MYC amplification is the only
identifiable cause of this circadian disruption in NSCLC. While CLOCK-BMAL1, and thus, oscillation of the
molecular circadian clock, are necessary to maintain normal lung architecture and identity, we found that MYC
activation led to loss of normal lung alveolar epithelial identity and induction of inappropriate proliferation.
Notably, glucocorticoids have been shown to slow or halt the growth of some NSCLCs in preclinical and clinical
studies, and our preliminary data suggest that glucocorticoids fail to suppress proliferation of lung cells when
MYC is overexpressed. Taken together, we hypothesize that BMAL1 suppression and circadian disruption by
MYC in NSCLC is critical for loss of alveolar cell identity, the emergence of malignancy, and resistance to
glucocorticoids. To test this hypothesis, we propose two Aims. In our first Aim, we will interrogate the degree
to which MYC suppression of BMAL1 and disruption of the clock drive loss of lung alveolar cell identity and
malignant cell transformation. To test this, we will restore BMAL1 expression in MYC-amplified lung organoids,
mouse models. As part of this Aim, we will test the hypothesis that MYC prevents BMAL1 from binding its
typical DNA targets. We will also test the association between MYC, BMAL1, and malignancy in human tumor
samples. This will for the first time demonstrate that MYC disruption of the clock is critical in driving the earliest
stages of NSCLC development. In the second Aim, we will test the degree to which MYC and circadian
disruption suppress NSCLC response to glucocorticoids. We will determine, using in vitro and in vivo models
of NSCLC from mice and human patients, whether MYC overrides glucocorticoid-mediated growth suppression
via suppression of BMAL1. We will also determine the mechanism by which MYC controls the glucocorticoid
receptor and molecular clock response to glucocorticoids. Overall, these experiments will demonstrate that
BMAL1 is a tumor suppressive protein in NSCLC that is disabled by MYC to drive malignancy.

Public health relevance
Project Narrative The cells of all mammals have daily internal cycles that are known as circadian rhythms, and many cancers, including lung cancers, have disrupted or absent circadian rhythms, but the reasons for this and its importance for tumor growth are not well understood. Lung cancers may shut down their circadian rhythms to grow more rapidly and resist therapy, and this proposal aims to study the role of the common oncogene MYC in blocking lung cancer cells from having a normal circadian rhythm, which may cause normal lung cells to turn into cancer cells and lose their ability to stop growing when exposed to steroids, either those naturally produced from the body or those used in treatment. We will determine how restoring circadian rhythmicity prevents lung cells from becoming cancer cells, and whether restoring rhythmicity makes lung cancer cells stop growing when treated with steroids as a therapy.